Identification of the full scope of the CodY regulon in Clostridioides difficile

ABSTRACT
Clostridioides (formerly Clostridium) difficile is a Gram-positive, sporulating, anaerobic bacterium that
can cause severe disease, including antibiotic-associated diarrhea and pseudomembranous colitis, in humans.
Pathogenic C. difficile produces at least two potent toxins, TcdA and TcdB, which cause major intestinal
damage to the host. Formation of spores by C. difficile is critical for survival of the organism in the environment,
initiation of infection (normally caused by spores), and recurrence of the disease due to re-germination of
spores formed in the gut of infected humans or animals and their ability to cause a new round of infection. A
global transcriptional regulator CodY appears to be the most important regulator of toxin-encoding genes, and
codY mutants of C. difficile produce more toxins and are more virulent than wild-type strains in a mouse model
of infection. CodY also controls expression of genes involved in sporulation, and codY mutants sporulate more
efficiently. Moreover, CodY affects expression of multiple metabolic pathways that are likely to be important for
growth and virulence. Although CodY is known to directly repress the tcdR gene, encoding a toxin-specific
sigma factor, the mechanism of CodY’s effect on toxin gene expression has not been fully established. The
direct targets of CodY that control C. difficile sporulation gene expression and spore formation remain
completely unknown.
To understand in full the mechanisms of CodY’s effect on C. difficile virulence, sporulation, and
metabolism, it is essential to determine the full scope of the direct CodY targets via identification at single-
nucleotide detail of the entire complement of CodY-binding sites. Therefore, we propose to determine the
entire set of genes that are able to interact with CodY directly either in vivo or in vitro. Using a novel approach,
in vitro DNA affinity purification coupled with massively parallel sequencing (IDAP-Seq), we are now able to
visualize CodY-binding sites in vitro on a genome-wide basis at near single-nucleotide resolution and rank the
sites according to their relative strengths. In addition, we will use ChIP-Seq experiments, also at near single-
nucleotide resolution, to define the genome-wide set of sites that interact with CodY in vivo. Comparing the
data generated by these approaches with the results of in vivo expression analysis (RNA-Seq) will allow us to
(a) identify direct and indirect targets of CodY regulation; (b) determine whether the breadth of the CodY
regulon is significantly greater than presently known; (c) uncover potential targets of CodY responsible for its
effect on sporulation; (d) find the genes that are potentially subject to dual control by CodY and other
regulators; and (e) establish whether premature transcription termination within coding sequences is involved
in CodY-mediated regulation of toxin-encoding and other C. difficile genes. The precise information on the
locations and relative strengths of CodY-binding sites for critical genes will provide the foundation for future
research on the detailed mechanisms by which CodY regulates individual genes.

Public health relevance
NARRATIVE Clostridioides (formerly Clostridium) difficile is an important pathogen that can cause severe disease, including antibiotic-associated diarrhea and pseudomembranous colitis, in humans; its virulence correlates with production of toxins, and re-initiation of infection is dependent on the cells’ ability to form spores. CodY is a major regulator of sporulation and toxin-encoding genes, but the entire scope of the CodY regulon is not known and the mechanisms of CodY’s effects have not been fully determined. We propose to fill this gap in knowledge and determine with very high precision the entire genome-wide set of loci responsible for the interaction with CodY and, therefore, delineate the full complement of genes that CodY affects directly and suggest the possible mechanisms of CodY’s action on individual genes.